Genetics of Mullerian Development

ABSTRACT
Uterovaginal developmental abnormalities occur in ~7-10% of women and impair reproductive function.
Congenital absence of the uterus/vagina, known as Mayer-Rokitansky-Kuster-Hauser (MRKH) syndrome,
represents the most drastic Mullerian anomaly. Other problems such as unilateral renal agenesis, skeletal,
cardiac, deafness, and emotional stress may occur in MRKH. There is a genetic predisposition, and autosomal
dominant (AD) and genetic heterogeneity are likely. Many candidate chromosomal regions and genes have been
studied, but there is only convincing evidence for mutations in 2 genes (WNT4 and HNF1B) as determined by in
vitro analyses and family studies. A critical barrier to diagnose and counsel MRKH women is the lack of
understanding of its pathogenesis. We found a new gene—ZNHIT3—by whole exome sequencing (WES),
supported by a de novo heterozygous frameshift mutation, two intragenic exon 5 deletions, three whole gene
deletions, and two 17q12 deletions including ZNHIT3. ZNHIT3 is zinc finger protein important for post-
transcriptional modification, which we showed is expressed in the human uterus, kidney, and heart. Our goal is
to understand the molecular basis and pathogenesis of urogenital anomalies by identifying genetic causes of
MRKH. Genes and mechanisms identified as a result of this proposal support our translational strategy to identify
and understand pathways important in human Mullerian development. Our central hypothesis is that MRKH is
AD, and is caused by intragenic mutations and copy number variants (CNVs). Our expected outcomes include
the identification of genes causing MRKH and associated anomalies. The impact of our findings include:
providing the basis for improved diagnosis, genetic counseling, and prevention of MRKH; and increasing our
understanding of normal Mullerian developmental pathways, which are relevant to more common, less severe
anomalies. Aim 1: We hypothesize that point mutations, splicing mutations, and CNVs will be present in ZNHIT3,
perhaps a hotspot for CNVs and rearrangements. We will perform RT-PCR and Sanger DNA sequencing on
MRKH patient lymphoblast RNA to identify multiple types of mutations in one assay. We will determine in vitro
effects of human ZNHIT3 variants and generate a Znhit3 knockout mouse model. Aim 2: To test the hypothesis
that MRKH is AD, we will perform WES on 43 quads and 26 trios and filter with standard methods, and use
Cartagenia, PhenoDB, and pVAAST to determine MRKH inheritance. We will perform whole genome sequencing
(WGS) to identify variants that would be missed by WES in well characterized quad families. Identified variants
will be confirmed by Sanger sequencing. Aim 3: Perform a comprehensive analysis of MRKH families to
determine the frequency and spectrum of variants in known and suspected MRKH genes by RT-PCR from
lymphoblast RNA and Sanger sequencing. Our strong preliminary data, large family cohort, innovative approach,
and interdisciplinary research team will instigate significant advances in human Mullerian development as
outlined by the Fertility & Infertility Branch of the NICHD.

Public health relevance
Project Narrative Congenital absence of the uterus and vagina, also known as Mayer-Rokitansky-Kuster-Hauser (MRKH) syndrome (the name patients prefer), represents the most drastic developmental anomaly of uterus and vagina. Other problems, such as missing one kidney, skeletal problems, heart anomalies, deafness, and emotional stress may be part of MRKH. Very little is known about genetic causes of MRKH, but we plan to identify new genes using next generation DNA sequencing and study genes proposed by other investigators to see if they cause MRKH and how frequent they are.